Senderos a la Ciencia/Pathways to Science Hispanic Role Model and Mentoring Project

Senderos a la Ciencia (Pathways to Science) Hispanic Role Model and Mentoring Project
Led by Hispanic Access Foundation, the Pathways to Science project will conduct bilingual public
outreach to Hispanic communities in New London, Connecticut in the venue of a Hispanic-serving
church. By featuring thrilling talks by Latino role model health science researchers, and by offering
follow-up near-peer mentoring to interested high school students, this project aims to (1) build
awareness and value among Hispanic parents and youth in targeted under-resourced Hispanic
communities of careers in health research; (2) engender an interest to pursue health research careers
among youth in these same communities; and (3) trigger pursuing a college path in health research
among high school students in these same communities. In order to achieve these aims, the project will:
(1.1) Recruit nine Hispanic role model scientists yearly to provide talks to parents and youth. (1.2) Coach
these scientists to offer exhilarating, engaging, and informative talks. (1.3) Offer monthly talks each
school year during Program Years 1-4. (1.4) Attract at least 400 Hispanic church goers to attend at least
one talk and at least 300 Hispanic church goers to attend two or more talks during all program years.
(1.5) Feature videos of these same talks on the project website. Further objectives will be to: (2.1)
Promote youth churchgoers’ identification with the role models featured in the talks. (2.2) Build
assurance among youth that they can pursue health research science careers. Objectives under aim 3
will be to: (3.1) Recruit and train up to 40 near-peer mentors on how to offer college prep coaching,
including both male and female young Latino health/biological science professionals who have
completed their college degrees. (Project Years 1-4). (3.2) Recruit up to 160 Latino high school students
who have attended at least one role model talk to participate in college prep coaching (Project Years 1-
4). (3.3) Offer at least one year, and up to two years, of college prep coaching to each mentee (Project
Years 1-5) and supervise mentor/mentee relationships. Year 5 of the project will entail dissemination of
project results among a network of pastors representing 150,000 Hispanic churches. Project evaluation
will be conducted by the independent evaluator, Knology.
1

Public health relevance
Project Narrative The Senderos a la Ciencia/Pathways to Science project is specifically designed to enhance workforce diversity in the health research sciences space. By offering role model talks featuring Hispanic health research professionals at a Hispanic-serving church, and by providing near-peer mentoring to Hispanic high school students interested in pursuing health science research careers, this initiative will: 1. Build awareness and value among Hispanic parents and youth in targeted under-resourced Hispanic communities of careers in health research. 2. Engender an interest to pursue health research careers among youth in these same communities. 3. Trigger pursuing a college path in health research among high school students in these same communities. Besides initially serving Hispanics in the greater New London, Connecticut community, this project will have the potential to reach much broader Hispanic audiences. Role model talks will be featured on the project website, which will be promoted via Hispanic Access Foundation’s bilingual social media accounts. Altogether, we foresee 1,000 unique visitors to these web pages during the project period. In addition, during the dissemination phase of this project, Hispanic Access Foundation will reach out to our network of pastors representing 150,000 Hispanic-serving churches. Interested pastors will be invited to attend replication seminars where they may learn about the Senderos/Pathways project and receive guidance for launching similar projects in their own communities.